Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative and Clinical Research Core provides the operational structure necessary for the planning,
implementation and management of all P01 activities and promotes the efficient, progressive and successful
conduct consistent with the program goals and P01 mission. It also provides administrative coordination,
oversight and research support services to all leaders, co-leaders, investigators and core directors.
A website, which includes secure intranet pages and forms, is used to more efficiently communicate and track
P01 resource requests and manage shared resources and core services to best serve P01 projects and themes.
The Core promotes efficiency and ensures that all P01 research and activities are focused and connected,
complex scientific objectives are met, and existing cancer center resources are utilized and not duplicated.
Finally, the Core provides required project oversight, monitoring and auditing to ensure projects are meeting
stated endpoints consistent with the P01 research plan and adhering to all regulatory requirements.
SPECIFIC AIMS
Aim 1: Establish and oversee a capable and responsive administrative apparatus to support the FACTR Center’s
scientific goals and operational needs.
Aim 2: Coordinate research interactions (meetings, collaborations, etc.) between the Projects and Cores.
Aim 3: Coordinate scientific communications between the DTSPC Program leadership, the NCI, and the broader
prostate cancer community to establish and sustain partnerships and further the overall goals of the Program.
Aim 4: Provide fiscal oversight and assist with obtaining compliance approvals (IRB, IACUC) for the Projects
and Cores in accordance with Federal, State, and institutional requirements.
Aim 5: Coordinate and represent the DTSPC Program within the administrative and scientific structures of the
participating institutions.
Aim 6: Organize and conduct timely meetings with the Scientific Advisory Board.
Aim 7: Manage and oversee clinical research needs of the DTSPC research projects.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE This program project was constructed to address the critical need for understanding and overcoming the problem of acquired resistance to prostate cancer therapy. The Administrative Core will serve to integrate and enhance the research conducted by the Projects and Cores through the provision of general administrative support and the facilitation of communication and data dissemination. Robust clinical research infrastructure and support, including consenting, specimen acquisition, distribution and clinical data dissemination, will support all Projects and Cores to ensure robust and efficient translation of the results generated in this proposal.